Core F: Induced Pluripotent Stem Cell Core

PROJECT SUMMARY - INDUCED PLURIPOTENT STEM CELL (CORE F)
Genome wide association studies (GWAS) have identified over 80 loci and candidate genes that are associated
with altered risk of developing late-onset Alzheimer’s disease (AD). Similar approaches are also increasingly
being used to identify loci associated with many other AD-Related Disorders (ADRD). Yet, precisely how these
candidate genes impact the function of human cells to either promote or protect against the development or
progression of AD/ADRD remains unclear. One promising approach that is increasingly being used by many in
the field to examine such questions involves the use of induced pluripotent stem cells (iPSCs), which can be
generated from control, AD, and ADRD participants and then differentiated into the key brain cells implicated in
AD/ADRD. In 2013, the UCI Alzheimer’s Disease Research Center (ADRC) became the first Center in the
network to establish a dedicated iPSC Core. Since then, the iPSC Core has generated over 400 AD/ADRD-
related iPSC lines, including >120 CRISPR-edited isogenic pairs, and disseminated this unique resource to over
71 research groups around the world. In the current application, the iPSC Core will continue to embrace new
advances in AD/ADRD genetics and CRISPR gene editing to generate and distribute additional highly unique
iPSC lines generated from participants within the ADRC’s Clinical, Oldest-Old, and Down Syndrome Cores.
Through four specific aims, the iPSC Core will employ innovative genetic studies and genome engineering to
facilitate the study of genetic AD/ADRD risk factors across special populations (Aims 1, 2, 3), collaborate with
AD/ADRD researchers worldwide (Aims 1-4), and educate the research and lay communities about the exciting
scientific applications and implications of AD/ADRD iPSC research (Aim 4).